Neural Circuit Mechanisms of Peripheral Nerve Stimulation for Trigeminal Neuropathic Pain

PROJECT SUMMARY/ABSTRACT Trigeminal neuropathic pain (TNP) is characterized by constant unilateral
facial pain caused by a lesion or disease affecting the trigeminal branch of the peripheral nervous system. This
type of pain is non-triggerable, unremitting, and varies in intensity. Clinically, TNP poses a significant therapeutic
challenge due to a lack of understanding of its pathophysiological mechanisms. Opioids are commonly used to
treat this condition, often combined with other medications and interventional pain procedures. However, long-
term opioid use leads to tolerance and dependence, necessitating escalating doses to maintain pain relief.
Peripheral nerve stimulation (PNS) has emerged as a promising treatment for neuropathic pain, including TNP,
without the concerns of tolerance and dependence associated with opioids. Despite its clinical use, the
underlying analgesic mechanisms of PNS remain unclear. Evidence suggests that the thalamic reticular nucleus
(TRN) plays a crucial role in sensory processing and pain regulation. Animal studies have shown that PNS
increases TRN firing in rats and that activating the ventral TRN reduces pain sensitivity in mice. Clinical evidence
indicates altered neuronal discharge in the TRN of patients with neuropathic pain. These findings highlight the
TRN's importance in neuropathic pain regulation. Our preliminary data showed that PNS effectively alleviated
hyperalgesia and suppressed ventral posteromedial nucleus (VPM) hyperactivity induced by infraorbital nerve-
chronic constriction injury (IoN-CCI) in mice. c-Fos mapping and intravital imaging revealed that PNS activates
TRN GABAergic neurons. Chemogenetic inhibition by designer receptors exclusively activated by designer drugs
(DREADDs) of these PNS-activated TRN interneurons abolished the PNS effect of analgesia and suppression
of VPM hyperactivity in IoN-CCI mice, while activation of the PNS-activated neurons produced similar analgesic
effects to PNS, attenuating IoN-CCI-induced hyperalgesia and VPM hyperactivity. Immunofluorescence staining
indicated that the activated TRN cells were predominantly parvalbumin (PV)-expressing neurons (PVNs), and
neural tracing in PV-Cre mice showed that these TRN-PVNs primarily project to VPM glutamatergic neurons.
Based on these preliminary findings, we hypothesize that the TRN-PVNs activation and the inhibitory projection
from TRN to VPM excitatory neurons are crucial to the analgesic effects of PNS. Our proposed aims are: 1) To
examine whether the TRN-PVNs is involved in the analgesic effect of PNS in IoN-CCI mice. 2) To investigate if
the inhibitory projection of TRN-PVNs to VPM excitatory neurons contributes to the PNS effect on dampening
VPM hyperactivity induce by IoN-CCI. We plan to use the Cre-loxP system for optogenetic manipulation of TRN-
PVNs in PV-Cre mice to determine the role of the PVNs in the PNS analgesic effect for TNP. Multidisciplinary
approaches including DeepLabCut machine learning, multichannel two-photon imaging and optogenetics will be
applied. This proposed work will provide a novel conceptual framework for understanding the neural circuit
mechanisms of PNS and generate proof-of-concept data for new circuit-based manipulations for TNP treatment.

Public health relevance
This project aims to elucidate the neural circuit mechanisms underlying the analgesic effects of Peripheral Nerve Stimulation (PNS) for Trigeminal Neuropathic Pain (TNP). By employing cutting-edge techniques such as intravital multiphoton imaging, optogenetics, chemogenetics, and machine learning-based behavioral analysis, this study will provide novel insights into the role of the neural circuit of thalamic reticular nucleus (TRN) and ventral posteromedial nucleus (VPM) in mediating PNS-induced analgesia. The findings from this research will provide a novel framework for understanding PNS mechanisms and generate proof-of-concept data for new circuit-based manipulation for TNP.